ARRAY BIOPHARMA PARTNER TIME

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Structural studies will be performed of biochemical systems to obtain knowledge that will form the basis for drug design and therapeutic approaches.